Regulation of age-related bone loss by PKIgamma

ABSTRACT
Age-related trabecular bone loss begins in young adulthood and leads to increased rates of osteoporosis and
fractures in elderly men and women. It is fastest in vertebrae, where it is ~2-fold faster in women than in men,
and then accelerates in post-menopausal women. Stimulation of cAMP/PKA signaling by intermittent Parathyroid
Hormone-like (iPTH) drugs (teriparatide or abaloparatide) is the only FDA-approved osteoporosis therapy that
acts by increasing anabolic bone formation rather than by decreasing bone resorption. However, not all patients
respond, therapy is limited to 24 months, and the anabolic effects are not maintained after cessation. Moreover,
iPTH therapy requires daily injection and is extremely expensive (~$30,000/year). We previously discovered that
knockdown or deletion of Protein kinase inhibitor  (Pkig) increases the anabolic processes induced by PTH/PKA
in vitro. Targeting PKI might therefore increase the magnitude of response, or the percent of patients who
respond, to iPTH therapy. Because the in vivo roles of PKI and the other two PKI family members were
previously unknown, we generated Pkig-/- mice. Our preliminary results indicate that genetic deletion of Pkig
overcomes both the age-related loss of bone volume and the age-related decline in skeletal healing.
Our long-term goal is therefore to determine whether PKI is a potential therapeutic target, either alone or in
combination with iPTH, to overcome age-related bone loss, the age-related decline in skeletal healing, and/or
post-menopausal bone loss. Our overall hypothesis is that PKI mediates age-related bone loss and the
age-related decline in skeletal healing by regulating the balance between osteogenesis and adipogenesis in a
sex- and skeletal site-dependent manner. The overall hypothesis will be tested by the following Aims:
Aim 1: Determine whether the effects of Pkig deletion on bone homeostasis depend on age, skeletal site, sex,
and/or iPTH therapy.
Aim 2: Determine mechanisms that are critical for regulation of age-related bone loss by PKI.
Aim 3: Determine whether Pkig deletion (either alone or in combination with iPTH) overcomes the age-related
decline of fracture healing and/or ovariectomy (OVX)-induced bone loss.

Public health relevance
NARRATIVE This proposal will substantially increase understanding of the mechanisms that regulate PKA signaling and age-related bone loss. This proposal will also determine whether PKIis an exciting potential therapeutic target, either alone or in combination with iPTH, for age-related bone loss, the age-related decline in fracture healing, and/or post-menopausal bone loss. Such results would lead to more translational Future Directions targeting PKI (Section 3.4).